General Clinical Research Center

EXCEED THE SPACE PROVIDED. General Clinical Research Center, Johns Hopkins Bayview Medical Center, Baltimore, MD GCRC Exercise Testing and Training Facility, The Johns Hopkins Asthma and Allergy Center, Baltimore, MD Core Laboratory, Johns Hopkins Asthma and Allergy Center, Baltimore, MD Timonium Outreach Exercise Research Center, Timonium. MD